MOLECULAR BIOLOGY OF CELLULAR INJURY

The major focus of this research group is the study of responses to genotoxic stress in mammalian cells. This has included the cloning and characterization of a variety of DNA-damage-inducible (DDI) genes. Studies have involved mammalian genes such as the gadd genes, beta-polymerase, metallothionein, and ubiquitin. Understanding the role of DNA-damage responses in determining the cellular sensitivity to cytotoxic agents. such as used in cancer therapy, is a major objective: efforts include DDI gene expression in drug-resistant tumor cells (formerly project Z01 CM 07187-02 LMPH). An important response to genotoxic stress in all cells are delays in cell cycle progression which are induced by DNA damage. Such delays can have a protective effect since mutants lacking growth arrest responses are hypersensitive to certain DNA-damaging agents. These delays are mediated by various genes and probably include the gadd genes which are both DDI and growth-arrest inducible and which were cloned in this laboratory. The major portions of this project focus on: 1) the study of the expression of these genes and characterization of the cDNA clones for these five genes: 2) the regulation of these genes with particular emphasis on gadd45; 3) the characterization of the gadd proteins with the development of high-affinity antibodies; 4) attempts to elucidate the function of these genes using expression vectors and antisense approaches; 5) the use of a transgenic mouse models to study the roles of these genes in vivo. Of particular interest is our recent finding that the induction of the human GADD45 gene by certain DNA-damaging agents is mediated by the p53 tumor suppressor. In collaboration with M. Kastan and B. Vogelstein, we have found that this gene is only induced by x rays in cells with a p53 wt phenotype. In addition. both the human and hamster gadd45 genes contain a conserved p53 consensus sequence which strongly binds p53 protein. These findings are the first demonstration of a cellular gene whose activation is dependent on p53. This may have important implications in cancer therapy considering that approximately two thirds of human tumors lack normal(wt) p53 function.